Orbitofrontal modulation of dopamine during value-based decision-making

Project Summary
Dopamine is an important neuromodulator that mediates learning from previous outcomes (“retrospective”
learning) by encoding reward prediction errors — the difference between experienced and expected rewards.
However, recent work has suggested that dopamine might use the prefrontal cortex to encode more abstract
prediction errors, such as errors about the hidden state of a task or environment. The exact circuit mechanisms
underlying these abstract hidden-state prediction errors remains unclear. This proposal has two major goals.
First, I will characterize dopamine activity related to hidden-state inference in rats performing a task with partially
observable states. Second, I will identify the circuit mechanisms that generate dopamine state prediction errors
in this task. I will use computational modeling and state-of-the-art genetic and viral tools, including fiber
photometry to measure dopamine activity and projection-specific chemogenetic silencing of prefrontal cortex, to
address these goals. I will measure dopamine activity both at the level of cell-body calcium dynamics, as well as
at the level of axonal release, which can be dissociated. This proposal will describe the multi-regional neural
circuits that underlie the acquisition and maintenance of abstract representations of the environment. The results
will provide insight into the pathology and treatment of neuropsychiatric disorders, which are characterized by
disrupted reward processing.
My co-sponsors at New York University (NYU), Dr. Christine Constantinople and Dr. Paul Glimcher, have
complimentary experience in behavioral and systems neuroscience experiments in rats, and computational
modeling of decision-making, respectively. The training I will receive will allow me to pursue truly integrative
research that involves the close interplay between experiments and theory. The strong, collaborative
environment at NYU makes it an ideal place for me to pursue these research goals. My training plan provides a
detailed strategy for acquiring the necessary skills from a team of co-mentors with extensive, proven expertise
in the relevant techniques. Technical training, as well as frequent data presentations, attendance of professional
courses, seminars, and conferences, and development of my writing and leadership skills will equip me to
complete the proposed research, and transition to a post-doctoral position in my field of interest.

Public health relevance
Project Narrative Our previous experiences can influence our future choices in many ways, for example by biasing choices towards actions that have been successful in the past (“retrospective decision-making”), or by choosing actions that you think will be successful based on careful mental planning (“inferential decision-making”). Biologically, retrospective decision-making is thought to be mediated by dopamine, though recent work has also suggested a role for dopamine in inferential decision-making. This proposal seeks to describe novel neural circuits that underlie inferential decision-making, the results of which will have applications in neuroscience, psychology, and machine learning.